Core F - Inclusion of Underrepresented Groups Core

PROJECT SUMMARY – INCLUSION OF UNDER-REPRESENTED GROUPS CORE (Core F)
The Inclusion of Under-Represented Groups Core or the IURG Core currently works with the Clinical; Outreach,
Recruitment and Engagement (ORE); Data Management and Statistical (DMS); and Biomarker Cores to identify
and resolve the barriers to research participation for African and Native Americans. The IURG has made inroads,
allowing us to enroll 290 individuals from URG, comprising 26% of the overall cohort, and we are poised to
expand this Justice, Equity, Diversity, and Inclusion (JEDI) focused work. The IURG Core will continue to be fully
integrated with the Center, assisting investigators to engage Native and African American, and Veteran
communities, ensuring adequate inclusion to answer scientific questions and optimize generalizability of findings.
The work proposed in this application will promote research focused on the biological underpinnings of healthy
aging, preclinical AD and the transition from MCI to AD dementia and ensure that science conducted at the
Wisconsin ADRC includes groups traditionally under-included in research. Briefly, the IURG Core will ensure
that participants from under-represented groups (URG) are included in the Wisconsin ADRC Clinical Core. In
support, we propose the following Specific Aims.
Specific Aim 1: In collaboration with the Outreach, Recruitment and Education (ORE) Core, the IURG Core will
adapt and tailor outreach, recruitment, and engagement activities to reach groups under-represented in
research. Specifically, efforts will focus on tailored approaches for African American and American
Indian/Indigenous groups. We will build on our Center’s work with military Veterans and will support ORE Core
efforts to expand Registry participation. Sub-Aims include supporting Community Advisory Boards (CABs),
leading community-specific outreach and engagement programs, developing culturally-safe, community-based
data collection processes, and developing stakeholder engagement opportunities.
Specific Aim 2: The IURG Core will provide consultation to support community engaged research with
individuals from URGs at two levels – both of which will grow Center-wide capacity for JEDI-centered research.
Sub-Aims include working with the Biomarkers and Neuropathology Cores to promote participation of individuals
from URG in biomarker sub-studies, and the Center’s Brain Donor Program, and to provide programed
consultation for teams seeking to increase inclusion of racialized groups into research studies.
The aims and activities described here align with and support the Center’s overarching scientific theme by
applying the JEDI principles – Justice, Equity, Diversity, and Inclusion in service of inclusive ADRD research.